APPLICATION OF BIOMECHANICAL STRESS ON PREVENTION OF BONE LOSS

It is the purpose of this study to examine the impact of various dynamic forces (functional electrical stimulation induced cycle ergometry) over a one year period on calcium metabolism after an acute spinal cord injury.